Molecular Targets for Cancer Detection and Treatment

This Molecular Targets Training Program has to meet workforce needs for scientifically trained medical oncology physicians who will translate increasingly technical knowledge in molecular biology to advances for cancer patients. The Program has had a record of training leaders who have gone on to lead major research programs. Training faculty are highly accomplished, varied in background and span research programs but are singularly focused on timely fundamental and translational areas in molecular oncology. Among the 39 participating faculty included in this application, one-fourth are past trainees of the Program, including one of its Program Directors. Ninety-two percent of those who have completed the program have transitioned to research positions, and nearly all have remained in those settings with continued career advancement. The Program boasts a highly competitive applicant pool and more than one-third are dual-degree MD/PhD trained. The T32 Training Program is two years and trainees acquire critical thinking skills through hands-on projects in a supportive mentored environment. Program requirements have continued to evolve encouraging innovation and flexibility while formalizing didactic requirements and expanding opportunities for inter-disciplinary work that foster training across laboratory-translational boundaries. Learning opportunities in new areas have been expanded to support training in computational biology and acquiring skillsets increasingly required for a competitive research career. Opportunities to support training in grantspersonship and professional development have also been integrated. This Training Program is poised to continue to excel in meeting its goals and filling workforce needs that will serve cancer patient interests.

Public health relevance
PROJECT NARRATIVE This longstanding program is in its 40th year. It provides protected and mentored research training activities with the goal of preparing medical oncology physicians who will transform and advance the targeted treatment and prevention of cancer.